Atorvastatin Treatment of Cavernous Angiomas with Symptomatic Hemorrhage Exploratory Proof of Concept (AT CASH EPOC) Trial

Atorvastatin Treatment of Cavernous Angiomas with Symptomatic Hemorrhage
Exploratory Proof of Concept (AT CASH EPOC) Trial
PROJECT SUMMARY
More than a million Americans harbor a cerebral cavernous angioma (CA). Of particular concern is the
exceptionally high bleeding risk in the fewer than 200,000 cases who have suffered a recent symptomatic
hemorrhage, and the high cost and morbidity of stroke and potential surgical interventions in this setting. It
would be desirable to develop a drug that stabilizes the hemorrhagic CA lesion and lessen the burden of re-
bleeding. A decade of research has identified RhoA kinase (ROCK) activation as a signaling aberration
mediating vascular hyper-permeability and bleeding in CAs. ROCK inhibition therapy has been shown to blunt
of CA lesion development and hemorrhage in mouse models recapitulating the human disease. A similarly
robust therapeutic benefit was recently documented with the hydroxy-methylglutaryl-coenzyme-A reductase
inhibitor atorvastatin, and a demonstrably weaker effect by lower potency simvastatin. Atorvastatin, in wide
clinical use, achieves ROCK inhibition pleiotropic effect in humans, at approved and well tolerated doses. The
Chicago team has implemented and validated novel magnetic resonance imaging techniques in CA patients,
reflecting lesional hemorrhage (quantitative susceptibility mapping, QSM) and vascular permeability (dynamic
contrast enhanced quantitative perfusion, DCEQP), and linked these measures to clinical hemorrhage in
human subjects. These discoveries have motivated a prospective, randomized, double-blinded, placebo-
controlled, Phase I-IIa exploratory proof of concept trial assessing the effects of atorvastatin, at doses shown to
cause ROCK inhibition, on CA lesions that have recently bled. The primary objective shall evaluate whether
the treatment produces a difference in lesional iron deposition (QSM biomarker activity) compared to placebo.
Secondary aims shall assess the drug effects on a second biomarker (DCEQP vascular permeability), link drug
treatment to ROCK activity in peripheral leukocytes, examine signal effects on clinical outcomes and adverse
events, and query pre-specified subgroups. Accounting for all causes of potential attrition and missing data, the
study is powered to test the primary hypothesis by enrolling 80 subjects (40 each in placebo and atorvastatin
groups). Subjects will be followed for 2 years, with plans for futility analysis and adaptive change in sample
size based on observed biomarker effects at midpoint of the trial. This is the first therapeutic trial focused on
stabilizing a CA that had recently bled, using mechanistically targeted vascular permeability therapy with the
goal of lessening re-bleeding. It will answer the urgent call by the clinical and patient community to assess
objectively and scientifically whether the widely available (and in some ways seductive) statins may have a role
in CA therapy. A team of investigators and consultants and a robust trial readiness infrastructure have been
assembled to maximize the rigor of the proposed study and insure its successful execution. Implications of
positive and negative trial results are presented, and corollary go-no-go propositions, within the scope of a
broader therapeutic development roadmap. This trial has received U.S. F.D.A. IND Exemption #126840.

Public health relevance
PROJECT NARRATIVE There is no proven therapy to prevent re-bleeding and neurologic disability in cerebral cavernous angiomas with symptomatic hemorrhage, impacting up to 200,000 Americans. Taking advantage of firm mechanistic rationale, rigorous preclinical discoveries and novel biomarker validations, we propose the first exploratory proof of concept trial aimed at stabilizing a cavernous angioma that has recently bled, using a repurposed, widely available and well tolerated drug, with the goal of lessening re-bleeding and its clinical sequelae.